Alternative Splicing Directed Epigenetic Regulation in Brain Development

PROJECT SUMMARY/ABSTRACT
Brain development requires intricate regulation of transcription, splicing, translation, and chromatin remodeling,
but how these processes interconnect is not understood. We propose to elucidate how posttranscriptional
alternative splicing regulates the epigenetic programs of brain development. During brain development,
alternative splicing of a subunit of the chromatin remodeling BAF (BRG1/BRM-associated factor) complex,
DPF2, switches from the canonical DPF2-Short (S) to a longer brain-specific DPF2-Long (L) isoform due to the
inclusion of a highly conserved exon 7. This alternative splicing switch impacts transcriptional regulatory
programs in embryonic stem cells (ESCs) and neural progenitor cells (NPCs), where DPF2-S and -L isoforms
exhibit discrete binding preferences to chromatin regions marked by different histone modifications, selectively
recruiting the BAF complex to specific genomic enhancers or promoters. Failure to switch from DPF2-S to -L
during ESC differentiation into glutamatergic neurons promotes the proliferation of non-neuronal cells and
reduces differentiation into neurons. However, how the brain-specific DPF2-L isoform functions in the epigenetic
regulation of the brain remains unknown. We propose to determine how the splicing switch of DPF2 controls
transcriptional and chromatin regulatory programs and neuronal maturation during brain development. By
utilizing CRISPR/Cas9-mediated genome-edited ESC lines and mouse models expressing either DPF2-S or
DPF2-L, we aim to determine the heterogeneity of different neuronal and non-neuronal lineages and the
transcriptional regulatory programs driven by alternative DPF2 isoforms in in vitro glutamatergic differentiation
cultures, as well as in mouse brains. Because DPF2 functions as part of the BAF complex, we propose to map
genome-wide BAF complex recruitment and accessible open chromatin regions at different developmental time
points from embryonic to adult brains. We recently discovered that DPF2-associated BAF complexes reorganize
into smaller subcomplexes in older adult brains, and now propose to determine the subunit composition and
modular organization of these subcomplexes and map their chromatin recruitment to understand their specific
roles in regulating epigenetic programs associated with brain aging.

Public health relevance
PROJECT NARRATIVE We propose to determine how posttranscriptional regulation of a chromatin modifier influences the epigenetic programs of brain development. A substantial amount of mutational data on neurodevelopmental disorders highlights a high mutational burden of chromatin regulatory genes, yet the molecular mechanisms of pathogenesis are poorly understood. Understanding the regulation of chromatin modifiers at both the RNA and chromatin levels will allow us to comprehend the mechanisms of neurodevelopmental disorders and develop future targeted therapies.